Computational methods for phasing biobank sequence data

Project Summary
Next-generaƟon biobanks will contain sequence data for millions of individuals. This project will develop
genotype phasing methods for these immense data sets. Genotype phasing esƟmates an individual's
haplotypes, which are the two sequences of alleles that are inherited from the parents. Genotype phasing
is necessary in order to perform powerful haplotype-based analyses.
This project will develop computaƟonal methods that substanƟally reduce the cost of genotype phasing,
so that it is possible to phase large biobanks for an acceptable cost. In addiƟon, the project will develop
methods that allow marker ﬁltering, sample ﬁltering, and haplotype-based analyses to be performed
directly on highly compressed data. This will remove the need to decompress phased genomic data prior
to data ﬁltering or haplotype-based analyses.
This project will develop two methods that signiﬁcantly improve genotype phase accuracy. The ﬁrst
method will idenƟfy diﬃcult-to-phase heterozygous genotypes at run Ɵme and apply a special phasing
algorithm to these heterozygotes. The second method will increase the number of geneƟc markers
available for haplotype-based analyses by allowing less stringent quality control ﬁlters to be applied
without harming genotype phase accuracy.
Finally, the project will develop an open-source pipeline for phasing All of Us Research Program sequence
data, and it will apply this pipeline to phase each sequence data release. The phased sequence data will
be a shared resource that enables researchers to perform powerful haplotype-based analyses of All of Us
genomic data, which will increase the power to detect genomic variants that inﬂuence heritable traits and
diseases.

Public health relevance
Project NarraƟve This research will develop new methods and soŌware that improve our ability to determine which geneƟc variants are co-inherited from the same parent. These methods will improve scienƟsts' ability to idenƟfy geneƟc variants that increase or decrease risk of disease, and they will contribute to the prevenƟon, diagnosis, and treatment of heritable diseases in the United States and throughout the world.